Mechanisms of lack of senescence and inducible senescence in the genus Hydra

DESCRIPTION (provided by applicant): Existing data suggest that the invertebrate species Hydra vulgaris does not show increased mortality with age. Interestingly, a closely related species, H. oligactis, shows increased mortality and physiological deterioration following induction of sexual reproduction. The long- term goal of this project is to identify the causes of this striking difference in longevity. Aspects of the biology of the Hydra vulgaris and Hydra oligactis suggest that some mechanisms affecting lifespan in other animals may contribute to the difference between the two species. Hydra oligactis induced to reproduce sexually form large numbers of gametes well before the onset of increased mortality. In addition, Hydra oligactis are less tolerant than Hydra vulgaris of environmental stresses such as thermal stress, and they fail to produce detectable levels of new proteins in response to heat shock conditions. Working with animals treated to eliminate the stem cells which produce gametes, we will investigate the possibility that, as in Caenorhabditis elegans and Drosophila melanogaster, germ cells in H. oligactis can reduce lifespan. By examining gene expression and producing transgenic animals which inducibly overexpress genes of interest, we will investigate the roles of genes involved in the heat shock response and the role of the transcription factor FoxO in H. vulgaris and in H. oligactis before and after induction of sexual reproduction and senescence.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed project will investigate the differences in regulation of lifespan in two closely related species, Hydra vulgaris and Hydra oligactis. It will focus on possible roles of signals from the germline, proteins involved in the heat shock response, and the transcription factor FoxO. As amply demonstrated by information gained from Caenorhabditis elegans and Drosophila melanogaster, work on the mechanisms of longevity control in invertebrate species can provide insight into the causes of human aging-related disease. Hydra have the potential to provide different types of information than these two well-developed invertebrate models, however, since in contrast to both species they are relatively long-lived. PROJECT NARRATIVE The proposed project will investigate the differences in regulation of lifespan in two closely related species, Hydra vulgaris and Hydra oligactis. It will focus on possible roles of signals from the germline, proteins involved in the heat shock response, and the transcription factor FoxO. As amply demonstrated by information gained from Caenorhabditis elegans and Drosophila melanogaster, work on the mechanisms of longevity control in invertebrate species can provide insight into the causes of human aging-related disease. Hydra have the potential to provide different types of information than these two well-developed invertebrate models, however, since in contrast to both species they are relatively long-lived. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The proposed project will address the following questions. 1) Is the presence of gametes required for induction of senescence in Hydra oligactis? We will produce H. oligactis which lack interstitial stem cells, the cells that give rise to gametes and neurons. We will determine whether conditions that induce senescence in normal H. oligactis induce it in animals which do not produce gametes, neurons, or the other interstitial lineage cell types. If our results indicate that interstitial lineage cells are necessary for the onset of senescence, we will produce H. oligactis which produce gametes but lack somatic interstitial lineage cells and determine whether senescence is induced in these animals. 2) Does reduced activity of heat shock factor 1 (HSF1) and/or heat shock proteins play a role in senescence in H. oligactis? We will compare expression of HSF1 and heat shock proteins in H. vulgaris, H. oligactis before induction of senescence, and H. oligactis after induction of senescence. To test the idea that the heat shock response may be abnormal in H. oligactis, we will produce transgenic H. oligactis which express HSF1 under the control of an inducible promoter. We will determine whether overexpression of HSF1 affects senescence in H. oligactis. 3) Does reduced activity of FoxO play a role in senescence in H. oligactis? We will compare expression of FoxO in H. vulgaris, H. oligactis before induction of senescence, H. oligactis after induction of senescence, and epithelial H. oligactis. We will also compare expression of genes known in other animals to regulate FoxO activity, and genes whose transcription is regulated by FoxO in other animals. To gain information about post- transcriptional regulation of FoxO activity, we will characterize cellular localization of a FoxO-GFP fusion protein in the four types of hydra mentioned. Finally, we will determine whether overexpression of FoxO affects senescence in H. oligactis.